Core C: Cell and Tissue

CORE C – CELL AND TISSUE
ABSTRACT/PROJECT SUMMARY
The purpose of the Cell and Tissue Core is to provide professional services and expertise to all Investigators of
the PCD Pig Program Project. The Cell and Tissue Core will provide: 1) technical assistance for labor intensive
techniques in cell culture, informatics and histotechnology, 2) professional specialized support for interpretation
of assays and analyses, 3) consultation and instruction in techniques and analysis and 4) economic benefits
through centralization of equipment, experienced professional staff and availability of specialized reagents.
Program Investigators will have full access to the Cell and Tissue Core's expertise and resources, and Core
personnel will provide services to Program Investigators in a timely and efficient manner.

Public health relevance
CORE C – CELL AND TISSUE NARRATIVE There is no Narrative for the Cell and Tissue Core.